Echogenic Targeted Liposomes:Transfection/Drug Delivery

DESCRIPTION (provided by applicant): Traditional means to identify and treat arterial disease are hampered by their inability to localize atheroma components. Novel targeted acoustic, highlighting, and delivery agents, such as liposomes, may overcome these problems. Liposomes are phospholipid vesicles enclosing an aqueous space. We have developed a unique methodology that, by process and composition, makes these liposomes echogenic. This formulation allows modification for antibody conjugation and therapeutic drug/gene incorporation. Preliminary work by this group has demonstrated that these formulations can incorporate therapeutics and deliver drugs and genes to cells while retaining their acoustic properties. The addition of therapeutic ultrasound has an added unique effect on these echogenic liposomes by increasing cellular delivery of the agents. This proposal describes a series of protocols aimed at optimizing therapeutic loading while retaining echogenic properties, quantitating echogenic properties, determining in vitro and in vivo therapeutic delivery and effect, and determining the effect of ultrasound forces on improving therapeutic delivery/effect. We will utilize one prototype drug (tissue plasminogen activator-rt-PA) in a clot/thrombus model and one prototype gene (Beta-galactosidase) in cell culture and an atheroma model. We will translate our therapeutic ultrasound experiments to a modified clinical ultrasound unit. This would allow the development of targeted, echogenic agents with therapeutic loading that could be directed locally with enhanced effect with added ultrasound forces to maximize atheroma effect while minimizing systemic actions. By focusing our experiment, our long term goal would be to bring our techniques into the clinical setting to allow investigators to stage atherosclerosis and apply more directed therapy to improve physiologic flow.